A randomized-controlled evaluation of the effects of climate impact menu labels on dietary quality

PROJECT SUMMARY
Poor dietary quality and high rates of diet-related chronic diseases such as type-2 diabetes are urgent national
public health priorities. Shifting dietary patterns in the United States (US) toward more environmentally
sustainable ‘planetary health’ diets has the potential to improve dietary quality and prevent diet-related chronic
diseases while also addressing climate change. Red meat consumption in the US is high and contributes to
both diet-related chronic diseases and climate change. Fast-food restaurants are a key environment to
promote ‘planetary health’-aligned food choices given the frequency of fast-food consumption, the poor dietary
quality of fast foods, and their adverse health effects. Numerous restaurants and food companies have recently
implemented climate-impact labels that inform consumers of each menu item’s carbon footprint (i.e., climate
impact). Climate-impact menu labels are also garnering interest among policymakers. Existing research shows
that nutrition labels can change behavior, but we lack evidence on whether climate labels can promote
healthier as well as more climate friendly food choices. Climate labels could improve dietary quality via lower
red and processed meat intake, but could also promote undeserved perceptions that unhealthy food items are
healthy (i.e., a ‘health-halo’ effect). Given the rapid development and growing food industry and policy interest
in climate-impact labels, there is a critical need for timely, rigorous evaluation of the real-world effects of
climate labels and the optimal design to maximize behavior change. The primary objective of this application is
to conduct two sequential randomized controlled trials (RCTs) to determine the degree to which climate-impact
menu labels influence the healthfulness of purchases at fast-food restaurants and overall dietary intake. The
first study aim is to conduct an RCT to compare the effects of different climate-impact menu label designs on
the healthfulness of hypothetical fast-food meal orders in a nationally representative sample of 6,000 US
adults. We will randomly assign 6,000 adults to view menus from two fast-food restaurants (one burger, one
sandwich) that display one of five types of label designs: 1) control (QR code), 2) green ‘low climate impact’
label; 3) red ‘high climate impact’ label; 4) ‘climate-score’ label; and 5) traffic-light label. The second aim is to
conduct an RCT to evaluate the effect of repeated exposure to climate-impact menu labels on the
healthfulness of real fast-food meal orders, delivered to the participant, over an eight-week period. We will
randomly assign 450 adults to one of two label conditions: control label vs. the label from Aim 1 that led to the
largest improvements in the healthfulness of menu items ordered. In the third aim, we will evaluate the
longitudinal effect of climate-impact menu labels on overall dietary quality (Healthy Eating Index scores)
assessed via multiple 24-hour dietary recalls. Results will provide policy relevant evidence to identify how
menu labels, a proven public health policy approach to change consumer behavior, can be used to improve
diet quality and diet-related health of Americans while also helping address the urgent threat of climate change.

Public health relevance
PROJECT NARRATIVE Strategies to shift food choices in the US toward a ‘planetary health’ dietary pattern, which is both more environmentally sustainable and healthier, are needed. This research project will use two sequential randomized controlled experiments to determine the degree to which climate-impact menu labels on fast-food restaurant menus influence the healthfulness of restaurant food choices and overall dietary intake. Results will provide critically important, timely, and actionable evidence to inform menu label policy and voluntary interventions to improve dietary quality and diet-related health of Americans while helping to address the urgent threat of climate change.